Myocardial Radiomics and Mechanics in the Pathology and Prognosis of Cardiovascular Disease

PROJECT SUMMARY
Though knowledge advances have been made in identification and treatment of risk factors, cardiovascular
disease (CVD) remains the leading cause of death in the U.S., and has been worldwide for the past 15 years.
The mechanisms of three leading sources of CVD morbidity, ischemic coronary artery disease, heart failure,
and atrial fibrillation, appear rooted in myocardial pathophysiology of the left ventricle (LV), suggesting that
deeper phenotyping of the LV may provide insight into the diseases. The detection of earliest forms of LV
dysfunction has been challenging: traditional measures of LV structure and function associated with poor
outcomes, such as mass and ejection fraction, reflect advanced stages of disease. However, recent advances
in quantitative imaging of the LV myocardium using cardiovascular magnetic resonance (CMR) images may
bridge this gap. Myocardial texture analysis is a type of ‘radiomics’, the computation of myocardial pixel
intensity and patterns, which has shown the ability to differentiate pathological patterns in LV hypertrophy.
Additionally, analysis of myocardial mechanics including strain and torsion have shown prognostic value in
evaluation of cardiomyopathies. Thus, increasing evidence indicates roles for these technological advances in
imaging analysis to evaluate pathological LV remodeling in subclinical cardiovascular disease in the general
population. We hypothesize that application of these novel imaging analytics, correlated with biology,
subclinical disease phenotyping, and outcomes, will enable more granular insight into subclinical LV structural
and functional changes predating overt CVD and its forms. The Framingham and Jackson Heart Studies,
community-based cohorts of whites and African Americans with longitudinal follow up, offer the opportunity to
gain insight in CVD development through integration of advanced secondary imaging analysis with detailed
and broad phenotyping and genotyping, and clinical end-points. Thus, the objectives of our proposal are
threefold: 1) to first identify myocardial texture analysis and mechanics patterns associated with prevalent CVD
and risk factors, 2) to define the biological and genetic underpinnings of these phenotypes, and 3) to
understand their inter-association between structure and function, and their joint relations with long-term
prognosis. Execution of our Aims will elucidate novel patterns, determinants, and prognosis of underlying early
and progressive myocardial remodeling and dysfunction in CVD in a large bi-racial cohort. Ultimately, our goal
is for knowledge gained from this study to advance phenotyping of LV remodeling groups, methods of
cardiovascular risk stratification, and development of therapies for patient care.

Public health relevance
NARRATIVE Cardiovascular disease remains the leading cause of mortality in the U.S., but its multi-factorial mechanisms and early detection are not well established. Applying new analyses of cardiovascular magnetic resonance images and integrating these measures with broad existing data including risk factors, genetics, and blood biomarkers, we will obtain deeper understanding of structure and function of the heart in older aged white and African American adults. Ultimately, accomplishment of this project will facilitate new strategies towards cardiovascular disease prevention and treatment.